CORE A-- PATIENT RECRUITMENT

SPECIFIC AIMS The goals of this core is to coordinate efficient patient recruitment for the projects described in the SCOR proposal. This core will function as a central facility to compile all patient data to enable investigators working on the SCOR projects to readily access patient information. This facility must be user friendly for the investigators but also secure to protect privacy. The specific aims of this core: Specific aim #1. facilitate and continue patient recruitment for all projects outlined in the SCOR proposal. Specifically we propose to recruit: a- 300 additional Bartter's and Gitelman's patients b- 350 additional ESRD affected relative pairs and 20 extended kindreds with ESRD c- 500 patients with hypertension in pregnancy d- Continue identification and recruitment of kindreds with Mendelian forms of hypertension of hypotension This will be achieved via direct targeted recruitment via questionnaires, screening and longitudinal follow-up of at risk family members for multiplex families, targeted field trips to recruit extended kindreds, referral via our physician collaborators, scanning the published literature and referral through identification of laboratory's projects via scientific meeting or via our website. We have also developed a secure customized database to facilitate data entry and storage, and permit retrieval and analysis of clinical data for investigators. Specific aim #2. Coordinate all clinical studies in SCOR in all inpatient and outpatient protocol in projects 1-3.